Carver College of Medicine Clinical Neuroscientist Training Program (CNS-TP)

PROJECT SUMMARY Brain diseases such as Alzheimer's disease, glioma, Parkinson's disease, and amyotrophic lateral sclerosis devastate the lives of millions of patients and their families. Despite decades of research costing billions of dollars, these and other brain diseases sorely lack diagnostic tools, effective disease- modifying therapies, adequate symptomatic managements, or even well-defined mechanistic causes. These failures stand out particularly in light of incredible advances in basic scientific knowledge. Thus there is a critical need for clinicians to be involved in basic research on human brain disease since they are well suited to identify new treatments. The University of Iowa Clinical Neuroscientist Training Program is designed as a more efficient pathway to train outstanding neurology and neurosurgery residents in basic research, with the goal of increasing the percentage of trainees who continue in a long career as productive clinician-scientists.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Physician scientists bring unique skills to scientific investigation and offer enhanced opportunities to translate basic scientific discovery to diagnosis and treatment of human disease. This program seeks to meet the need for more clinical neurologists and neurosurgeons trained in basic neuroscience.